Optimization of anti-LANA CD8+ as an therapeutic immunogen (Immune/Microenvironment)

Optimization of a modified immunotherapeutic LANA antigen for use in treating persons with HIV/AIDS
and refractory KSHV-related cancers (Immuno/Microenvironment).
ABSTRACT
This PA-20-272 administrative supplement to the UPMC Hillman Cancer Center Support Grant (P30CA047904)
is directly responsive to the Immunotherapy and Tumor Microenvironment in HIV/AIDS Cancer Patients at
NCI-Designated Cancer Centers Administrative Supplement Announcement for P30 Cancer Centers Support
Grants (CCSG). It focuses on research to 1) discover and characterize an immunotherapeutic target (KSHV
LANA), 2) by developing a new immunotherapeutic approach (protein engineering to enhance LANA peptide
presentation), that 3) improves our understanding of the immunosuppressive environment of KSHV tumors. It
is 100% aligned with NIH HIV/AIDS Research Priorities as a new and important approach to treat persistent or
recurrent AIDS-related Kaposi sarcoma (KS) in patients who have undergone immune reconstitution through
antiretroviral therapy. This proposal also addresses targeting KS in the aging KSHV+ HIV/AIDS population who
do not currently have KS but can be expected to be at high-risk for developing KS with aging.
The purpose of this study is to optimize LANA as an immunotherapeutic by changing the immunologically “cold”
LANA protein into an immunologically “hot” CD8+ cytotoxic lymphocytic (CTL) antigen. Our preclinical mouse
study, using an ovalbumin T cell peptide reporter, reveals that the LANA central repeat domain 1 (CR1)
specifically inhibits LANA proteolytic processing and MHC I peptide presentation to evade cell-mediated
immunity. By deleting the CR1 domain and expressing LANADCR1 in murine MC38 cancer cells, we provoke a
robust CTL response with specific recognition and cell killing by OT-1 CD8+ cells. When wild-type LANA-
expressing MC38 cells are injected into syngeneic, immune-competent C57BL/6 mice, mice develop
monotonically-growing tumors that require termination, consistent with LANA-induced CTL immune escape. In
contrast, mice injected with MC38 cells expressing LANADCR1 show brief tumor formation and then tumor
regression, consistent with an effective anti-tumor CTL response. Both LANA- and LANADCR1-expressing cells
generate indistinguishable tumors when injected into Rag1-/- mice demonstrating that this differential response
is due to immune surveillance.
During this proposal period, we will further optimize the LANADCR1 as an immunotherapeutic antigen by
fragmenting the corresponding ORF73 gene, performing codon-optimization and removing additional repetitive
peptide regions and the nuclear localization signal that may contribute to reduced CTL responsiveness. We will
immunize mice with the optimized antigen and, after an appropriate boosting schedule, challenge the mice with
wild-type LANA only-expressing MC38 cells to determine whether optimized antigen can prevent tumor formation
through LANA epitope recognition. Successful conclusion of this study will set the stage for moving this vaccine
candidate into mRNA nanoparticle or virus-vector antigen presenting vaccines for animal studies as a preliminary
step to Phase I trials.
1

Public health relevance
NARRATIVE Kaposi sarcoma (KS) is the most common cancer among AIDS patients and is caused by a virus our laboratory discovered called Kaposi sarcoma herpesvirus (KSHV). KSHV must express a protein, LANA, to survive in the cell and it has evolved to avoid host cellular immune responses. This proposal identifies these immune evasion pathways for LANA and eliminates them to develop a therapeutic vaccine that will harness the restored immune system to target KS in AIDS patients who have had immune reconstitution but still have persistent KS after antiretroviral treatment. 2